Medicare Advantage Today and Tomorrow

REVISED PROJECT SUMMARY/ABSTRACT
Enrollment in Medicare Advantage (MA), in which Medicare contracts out financial responsibility for beneficiaries’ care to private health plans, now exceeds enrollment in traditional Medicare (TM). The skyrocketing popularity of the Medicare Advantage (MA) program presents a double-edged sword for a rapidly growing senior population. While it offers them an alternative to TM through private health plans, concerns linger about how MA plans balance cost-containment practices with ensuring access to essential, high-quality services. Studies suggest practices like claim denials and limited networks, particularly concerning access to critical specialists like cardiologists and orthopedic surgeons, might restrict necessary care. This can potentially impact quality, with adverse welfare consequences for specific subpopulations. Additionally, the current diagnosis-based risk adjustment methods used to compensate plans may be susceptible to manipulation, potentially rewarding plans for focusing on less complex cases.
As an agent for its beneficiaries, Medicare has two main tools for encouraging private MA plans to add value. The first is to encourage competition, both from TM and within MA. The second is direct regulation of aspects of plan design and behavior — including utilization management, provider network restrictions, risk selection, and diagnosis coding or other rent-seeking strategies — through standards, oversight, and payment system methods. Optimal program design may leverage both strategies, but there are tradeoffs between relying on competition versus regulation. Existing evidence demonstrates that MA plans reduce use of care below TM levels, but little is known about whether strategies employed by MA are consistent with Medicare’s aims and how we should think about the need for, and design of, stronger regulation.
This motivates a set of interrelated areas of inquiry to fill in gaps in our knowledge that examine aspects of MA program performance under current competitive and regulatory conditions and explore the prospects of regulatory improvement through three specific research aims. The first aim will analyze the impact of utilization management practices such as claim denial rates and prior authorization requirements on use of care and test whether denials disproportionately impact more vulnerable subpopulations. The second aim seeks to provide new insights into network composition by assessing selective contracting for specialists and its implications for both access to and quality of care and exploring alternative approaches to assessing network adequacy based on care seeking patterns in TM. The third aim explores developing alternative approaches to risk adjustment using prescription drug and patient-reported health data that could mitigate distortionary coding incentives without exacerbating socially undesirable selection incentives.
Overall, this research intends to advance knowledge of MA plan performance under current policies to strengthen oversight and further enhance the program.